STRUCTURE &DYNAMICS IN DNA MOLECULES CONTAINING TRACTS OF AT BASE PAIRS

Tracts of AT base pairs play important roles in DNA packing and DNA recognition by proteins. Recent crystallographic results have suggested the existence of a unique structural feature in these tracts, namely, bifurcated H-bonds from the N6-amino groups of adenine of the O4 of the thymine in the next base pair and in the opposite strand. The presence of these bifurcated H-bonds could explain properties of AT tracts such as binding of the helix axis and abnormal base-air opening kinetics. In this project , we are using 15N and 1H NMR spectroscopy to : (i) establish the existence of bifurcate H-bonds in AT tracts of the DANA in solution state, and (ii) characterize the effects of bifurcated H-bonds upon the local conformation and dynamics of the AT base pairs. We have synthesized, by chemical means, the DNA dodecamer 5(-d(CGCAAATTTGCG)-3( in which the N6-amino groups of all three adenines contain 15N. As a control, we have also synthesized the dodecamer 5(-d(CGCGAGCTCGCG)-3( in which only one adenine is present and 15N-labeled at the N6 amino group. The local environment at the adenine bases is investigated by monitoring the chemical shift of 15N and 1H resonances as a function of temperature. The dynamic properties of each adenine amino group are characterized by 1H-15N NOEs, 15N-edited 1H-1H NOEs, 15N and 1H relaxation rates, and the rates of exchange of amino protons with solvents protons. The results thus far indicate that 1H-15N NOEs and/or amino proton exchange rates for the first two adenines in the A3T3 tract differ from those in a single, isolated AT base pair. These findings support the presence of bifurcate H-bonds in these AT base pairs.